Effect of Product Characteristics on the Abuse Liability of Nicotine Pouches

PROJECT SUMMARY
There is a growing sector of modern tobacco-free oral nicotine pouches (NPs) that are federally regulated as
non-medicinal nicotine/tobacco products. While NPs employ marketing approaches that may attract current
tobacco users, such as marketing themes connoting minimal harm, information on the long-term health effects
of NPs is lacking. NPs may appeal to young adults because they are available in similar product characteristics
(e.g., nicotine concentration, protonated nicotine) that many young people prefer to use in e-cigarettes. In
addition, NPs may be of particular interest to young adult e-cigarette users because these products can be used
discreetly where vaping is not allowed, which may translate into an increased likelihood of becoming dual users
of e-cigarettes and NPs. Indeed, approximately 15% young adults who used EC in the past 30 days were past
30-day NP users. Manufacturers of modern NPs use acid additives to lower pH, which changes nicotine from a
free-base to a protonated nicotine, resulting in improved appeal and sensory experience and higher abuse
liability. Thus, nicotine concentration and pH in modern NPs should be focal targets for regulatory policies.
Evidence is also lacking on mechanisms mediating differences in product appeal and abuse liability of NPs
across products varying in nicotine concentration and pH level. The scientific objective of this research plan is to
assess the effect of variation in nicotine concentration in NPs and its interaction effect with pH level on three
proximal outcomes of relevance to FDA regulation: (1) sensory attributes, (2) product appeal, and (3) abuse
liability among young adult dual users of NPs and e-cigarettes. This innovative project proposes to conduct
double-blind within-subject randomized clinical trials in which participants (N≈156 [Aim 1 N = 72; Aim 2 N = 84])
will administer NPs varied by nicotine concentration (e.g., 4 vs 2 mg) and pH (e.g., ≥9 vs ≤8, ≥1 point difference)
across two flavors (e.g., mint, fruit) to achieve the project aims: to evaluate the effects of nicotine concentration,
pH, and flavor on subjective product appeal and sensory attributes of NPs (Aim 1); to assess the effects of
nicotine concentration and its interplay with pH on abuse liability of NPs (Aim 2); to estimate the extent to which
sensory attribute mediates the pH-moderated effect of nicotine concentration on product appeal and abuse
liability (Aim 3). The findings of this proposed research will provide the FDA with new evidence necessary to
inform regulatory restrictions on product characteristics and constituents of NPs, which may put young adults at
risk of using a novel class of oral nicotine products. A career development plan that complements the research
plan builds on the applicant’s background in behavioral epidemiology and quantitative analytic skills, which
outlines new training in three areas: (1) clinical trial experiments testing the effects of exposure to tobacco
products on behavioral responses (e.g., abuse liability), (2) product characteristics and constituents of emerging
oral nicotine products, and (3) within-subject data and causal mediation analyses. The combined research and
training plan will prepare the candidate as an independent investigator with expertise in tobacco regulatory
science.

Public health relevance
PROJECT NARRATIVE Modern non-tobacco oral nicotine pouches with pH adjusted to enhance sensory experience and appeal of high- nicotine products may appeal to young people. The proposed project will conduct two double-blinded within- subject randomized clinical trials to examine the effects of nicotine concentration and pH and their interaction effects on behavioral responses such as sensory experience, product appeal, and abuse liability of nicotine pouches in young adult dual users of nicotine pouches and e-cigarettes. The results of the proposed research will be significant because it will complement current research on regulation targets with actionable insights on the modifiable factors related to initiation and use of a novel class of oral nicotine products.